STREPTOCOCCUS FAECALIS ENDOPHTHALMITIS

Because of the limited access to intraocular spaces by components of the immune system, bacterial endophthalmitis -- resulting from traumatic injury or arising as a post surgical complication -- frequently results in loss of useful vision in the infected eye. The advent of therapeutic measures including vitrectomy and intraocular antibiotic administration has proven valuable in salvaging sight in many eyes that otherwise would be lost to endophthalmitis. However, the prognosis in fulminant cases of endophthalmitis where the offending organism is known to produce cytotoxic factors remains poor. Prior to the development of sophisticated genetic techniques for manipulating bacterial expression of virulence factors, direct assessment of the contribution of cytotoxic bacterial products to disease was impossible. The bacterium Streptococcus (Enterococcus) faecalis provides a unique model for directly determining the role played by a cytotoxin in endophthalmitis for several reasons: 1) the only virulence factor thus far ascribed to the organism is a cytolytic toxin, 2) the cytolytic toxin is encoded by a mobile genetic element amenable to in vitro manipulation, 3) Iosgenic strains of S. faecalis specifically attenuated in expression of the cytolytic toxin have been constructed, and 4) S. faecalis has been observed to cause a significant proportion of more severe endophthalmitis cases and has been identified as the primary etiologic agent in cases involving filtering blebs. The goals of the proposed research are to establish a rabbit model for S. faecalis endophthalmitis and directly test the contribution of the cytolytic toxin in the disease model. Further, other cellular components and products produced by the organism will be tested for their contribution to the histopathology of S. faecalis endophthalmitis. Finally, antibiotic and anti-inflammatory therapies will be compared to assess their relative values in eliminating the infections and minimizing loss of vision.